Tobacco Treatment Specialist Training for Clinical Pharmacists to Advance Service Delivery for People Living with HIV

PROJECT SUMMARY
Smoking rates among people living with HIV (PLWH) are approximately 40-50%, over triple the rate in the general
United States population. The health effects of smoking on PLWH are significant, with PLWH losing more years
of life to smoking than to HIV-related morbidities. Because smoking is often not addressed in the context of HIV
care, few PLWH are offered evidence-based cessation treatment. Pharmacists are in a unique position to offer
tobacco treatment to PLWH as many clinics funded by the federal Ryan White HIV/AIDS Program have a
pharmacist on staff. As such, capitalizing on pharmacists’ roles in a comprehensive approach to HIV care, their
scope of practice could be expanded to offer tobacco treatment counseling and pharmacotherapy. The
ENHANCE-TTS (ENgaging pHarmacists to AdvANCE Tobacco Treatment Service delivery) program seeks to
increase tobacco treatment counseling in HIV care settings through a novel program with tools, training, and
facilitation support for systems change. Clinical pharmacists will be trained as Tobacco Treatment Specialists
and the training will follow with technical assistance and coaching to support the implementation of new practices.
This hybrid type II effectiveness-implementation study will use a stepped wedge design in 6 clinics in South
Carolina. We will evaluate the effects of ENHANCE-TTS on pharmacists’ tobacco treatment care delivery
adoption (pharmacotherapy prescriptions, tobacco treatment counseling codes) (Aim 1) and evaluate the
acceptability, feasibility, fidelity, implementation cost, and penetration of the approach (Aim 2). Aims 1 and 2 will
also characterize barriers and facilitators to implementation outcomes guided by the Consolidated Framework
for Implementation Research (CFIR). Finally, in Aim 3, we will evaluate the effects of ENHANCE-TTS on patient-
level tobacco treatment outcomes among PLWH using biochemically-confirmed 7-day point prevalence
abstinence outcomes at 3- and 6- months following the initial counseling appointment in a subsample of patients
(N=156) who received tobacco treatment from the clinical pharmacists. This study will examine a novel program
with tools, training, and facilitation support for systems change within HIV care settings to deliver tobacco
treatment to PLWH. Integrating effectiveness and implementation results will help define best practices for
pharmacist training and engaging clinic teams for practice change to ultimately provide high-quality evidence-
based tobacco treatment interventions to PLWH.

Public health relevance
PROJECT NARRATIVE The overall goal of this research is to improve care for people living with HIV through the delivery of high-quality tobacco treatment to address the high rates of smoking in this population. This research will test the effects of a novel program with tools, training, and clinic facilitation support that capitalizes on pharmacists’ roles by expanding their scope of practice to deliver tobacco treatment. This effectiveness-implementation study will evaluate the effects of the program on implementation outcomes and patient-level smoking cessation outcomes in people living with HIV and concurrently identify key barriers and facilitators to implementing this program in practice.